BASIC PHOTOELECTRIC STUDIES IN ORGANIC CONDENSED PHASE

Charges are produced in organic materials homogeneously by a multiphoton ionization mechanism. It is then possible to determine wavelength dependent ionization cross-sections at energies where the sample is opaque, but using light to which the sample is transparent. The transport of charges in organic materials is detected by a new interferometric technique. Finally the act of photoinduced charge-transfer is being probed by fluorescence lifetime measurements on the picosecond time scale.